Glycemic and Weight Loss Effects of Semaglutide in Subjects After Spinal Cord Injury and Type 2 Diabetes

Patients with spinal cord injury (SCI) develop diabetes at an earlier age and at a much higher rate than able
bodied individuals (AB). Those with SCI and T2D are at much higher risk of developing cardiovascular
complications. In addition to severe insulin resistance due to muscle atrophy and enhanced adiposity after SCI,
affected patients have impaired prandial insulin secretion along with autonomic nervous system dysfunction.
Yet, the optimal strategies to prevent or treat diabetes and obesity and related complications after SCI remains
unknown. Numerous therapeutic options based on glucagon-like peptide 1 receptor (GLP-1R) agonism
(agonists and co-agonists) are approved or in the pipeline for treatment of diabetes and obesity in AB patients
based on our understanding about their effectiveness and tolerability in this population. Among them,
semaglutide (SGT), which is the most potent GLP-1R agonist (GLP-1RA) in glycemic improvement and weight
loss, has shown to reduce cardiovascular death by ~25% in AB population. Our preliminary data demonstrate
that patients with SCI are treated with GLP-1RA at a 10-times lower rate than AB population. The cause for
this health disparity in diabetes management is unknown but could be partly due to the lack of insights into
anti-diabetic effectiveness and safety of GLP-1RAs in this high-risk population.
Our central hypothesis is that administration of semaglutide (SGT) in SCI population with T2D improves
glycemic tolerance and β-cell function (Aim1) and improves insulin sensitivity along with reduced fat mass but
preserved lean mass along with weight loss (Aim2). In Aim1, glucose tolerance, glucose fluxes, and β-cell
function during a meal tolerance test (MTT) combined with tracer infusion before and after 24 weeks of SGT
vs. placebo will be measured. In Aim 2, we will measure hepatic, muscle, and adipose tissue insulin sensitivity
using a 2-step (90 min/step) euglycemic insulin (15 and 80 mU/m2/min) clamp combined with tracer infusion
before and after 24 weeks of SGT vs. placebo. We will also explore potential changes in total fat/lean mass,
liver fat and fibrosis. Safety and tolerability will be assessed throughout the study.
This is a phase 4, single center, double-blind randomized, and placebo-controlled study. We will use approved
formulary medications according to their package inserts. All studies will be conducted at the Bartter Clinical
Research Unit, STVHCS (Director, Salehi, PI) or Texas Diabetes Institute, UHS (Director, DeFronzo, Co-I).
The SCI subjects (N=37; 18-70 yr of age, >1-year post-SCI, BMI > 22 kg/m2) with T2D treated with metformin
will be enrolled and randomized after completion of baseline studies. The established SCI cohort of patients
from STVHCS (N ~450) and UTHSA (N ~ 200) are available to be enrolled in the present study.
Gaining insight on the safety profile and mitigatory effect of GLP-1R activation on pathogenic factors that are
involved with glucose abnormalities after SCI, can facilitate the development and utilization of GLP-1R agonists
and co-agonists for treatment of diabetes and obesity in this population, improving health equity.

Public health relevance
Narrative Persons with spinal cord injury (SCI) develop diabetes more than able-bodied persons at an earlier age. Yet, the effectiveness and tolerability of recently developed anti-diabetic drugs, such as glucagon-like peptide 1 receptor agonists (GLP-1RAs), after SCI remains unknown, contributing to health inequity in diabetes management in this high-risk population. This project will examine the effectiveness of GLP-1R activation by 24-week administration of semaglutide on glucose tolerance, insulin action, and body lean/ fat mass in patients with SCI and diabetes subtype that manifests by severe sarcopenia and beta-cell and autonomic dysfunction in addition to exaggerated insulin resistance.